White Matter Metabolism in the Context of Aging, White Matter Hyperintensities and Alzheimer's Disease

ABSTRACT
White matter hyperintensities (WMH) are ubiquitous in the aging brain. Prevailing theories implicate
arteriosclerosis and endothelial dysfunction followed by ischemic and hypoxic injury as a cause, but factors that
resist or modify these mechanisms are unknown. Animal studies show that glycolysis is a principal metabolic
feature of normal white matter and protective against mitochondrial failure. However, white matter glycolysis has
been understudied in in vivo human studies and particularly in the context of WMH. Our laboratory has developed
methods, now on a state-of-the-art PET scanner, to quantitatively measure brain glycolysis using multiple
radiotracers, including 15O radiotracers to measure cerebral oxygen consumption (CMRO2), cerebral blood flow
(CBF) and oxygen extraction fraction (OEF), and 18FDG to measure total glucose use (CMRglc), from which we
can derive the rate of aerobic glycolysis (AG). Here we propose to apply these methods to provide gold-standard
quantitative estimates of normal human white matter metabolism, and to specifically investigate white matter
glycolysis in the context of WMH. In our first two aims, we will compare the topography of metabolic PET
measurements to MRI measurements of white matter microstructure and WMH, both in healthy adults without
WMH and in adults with WMH. In our third aim, we will analyze longitudinal MRI imaging data in a cohort of
adults who have already undergone metabolic PET in our prior and ongoing studies on an older scanner, to test
the hypothesis that relative differences in white matter glycolysis will predict subsequent WMH development and
progression. Moreover, we will explore potential relationships between neurodegenerative pathology and WMH,
which we hypothesize occurs due to effects of the aforementioned pathology on white matter metabolism,
thereby reducing its resilience to WMH.

Public health relevance
NARRATIVE The aging brain develops spots in the white matter that are visible on MRI, commonly called white matter hyperintensities (WMH), which has been associated with cognitive decline and is an important aspect of the vascular contributions to dementia (VCID). In this proposal, we aim to investigate whether glucose use in the white matter is relevant to WMH in humans as measured with state-of-the-art positron emission tomography (PET) studies of glucose and oxygen metabolism and brain blood flow. We aim for these findings to help us better understand WMH and white matter metabolism more generally and give us insight into how WMH can be prevented so that the risk of aging related cognitive decline can also be reduced.